CD4 Th1 and TCM as Modulators of Neuroinflammation

Project Summary
Anti-retroviral therapy (ART) has transformed the management of HIV, turning a once-fatal illness into a chronic
condition. However, the success of ART has also led to the emergence of chronic inflammatory diseases,
particularly neurodegenerative disorders, as a significant challenge. HIV-positive individuals are at a significantly
higher risk of developing HIV-associated neurocognitive disorders (HAND), with nearly half of those on ART
experiencing HAND symptoms due to persistent neuroinflammation. Infiltrating immune cells, alongside brain-
resident counterparts, are key drivers of neuroinflammation, yet targeting the central nervous system (CNS) T
cell infiltration remains largely unexplored.
Our R21 proposal aims to bridge this gap by targeting specific CD4 T cell subsets to uncover their roles and
interaction in the CNS and to develop innovative strategies to mitigate neuroinflammation. We will investigate
the role of T helper 1 (Th1) cells and T central memory (TCM) cells in driving acute neuroinflammatory processes
within the brain parenchyma and border tissues. We will use a highly relevant rhesus macaque model of HIV,
where SIV infection is followed by ART initiated on day 7 to simulate clinical conditions. In Aim 1, we will assess
the impact of a novel monoclonal antibody designed to block CD4 Th1 influx into the CNS and determine if this
intervention decreases viral loads and inflammatory profiles in regions such as the prefrontal cortex,
hippocampus, and other CNS areas. Aim 2 will explore whether additionally blocking CNS entry of CD4 TCM cells
further reduces viral loads and neuroinflammation. Through high-dimensional flow cytometry and comprehensive
virological analyses of distinct brain regions and border tissues, this study will provide insights into how CD4 Th1
and TCM cells contribute to neuroinflammation and CNS viral seeding. By targeting these specific CD4 T cell
subsets, we aim to uncover detailed mechanisms and explore potential interventions to mitigate
neuroinflammatory and neurodegenerative effects in HIV-infected individuals.

Public health relevance
Project Narrative Ongoing neurodegenerative complications in people with HIV, despite effective antiretroviral therapy, highlight the need to understand the immune mechanisms behind neuroinflammation and neurodegeneration. Infiltrating immune cells, especially CD4 T helper cells, are key drivers of this process, yet targeting CNS T cell influx is largely unexplored. To address this, we will use a relevant HIV model and a novel intervention to uncover how CD4 T cells trigger acute neuroinflammation and explore strategies to mitigate it.